Dentin Biomodification for Optimization of Bioadhesive Dental Restorations

SUMMARY
The most conservative and common treatment of missing dental tissue is direct resin composite restoration. Its
failure rate is high, lasting an average of 6 years. The primary reason for failure is the development of
secondary caries. An estimated 50% of resin composite interventions replaces failed restorations, leading to a
vicious restorative cycle with increasing complexity, poor prognosis for the tooth, and high treatment costs.
Resin-based restorations rely on micro-mechanical adhesion to enamel and dentin structures. Dentin is of
particular importance as it is the bulk of the tooth and tightly connected with the pulp tissue. It is well known
that components of the dentin extracellular matrix play major roles in the formation and sustainability of the
dentin-resin bonds. Bioinspired by natural dentin toughening mechanisms, our group identified refined mixtures
and isolated proanthocyanidins (PACs), a 3D structurally diverse class of biosynthetic polyphenols that can
mimic dentin natural processes. These molecules elicit enhancement to the mechanical properties and reduce
matrix biodegradability, collectively termed dentin biomodification. Additionally, we have revealed that PACs
can play multi-functional roles at the inherently wet dentin-resin interfaces. Therefore, PACs represent new
biomaterials with promising impact in the broader field of restorative/reparative dentistry. Notably, the PAC
sources of this project are renewable industrial waste and/or by-products, respectively, making them highly
sustainable from both economic and environmental perspectives. The ultimate goal is to develop a
mechanistically based and clinically feasible strategy to modulate permanent physico-mechanical properties of
the dentin matrix, to create more stable dentin-resin bioadhesion, and thus increase the longevity of resin
composite restorations. This will be accomplished by identifying features of specific molecules, ligand-PACs,
that mediate stable biomodification and durable dentin-resin interfaces. More specifically, this project will define
the structure activity relationships of ligand-PACs (a) to modulate the main components of dentin (extracellular
matrix and mineral) sustainably; (b) to establish and optimize bioadhesion mechanisms at the dentin-PAC-
resin interfaces; and (c) to tailor interfacial responses that directly affect performance and (pre-)clinical usage.
The Specific Aims are: (Aim 1) Define distinct mechanisms of interactions of ligand-PACs with the extracellular
matrix, mineral phase, and altered forms of dentin. (Aim 2) Elucidate and tailor ligand-PACs to produce robust
biointerfaces. (Aim 3) Determine the stability of the tooth-PAC-resin interfaces in relevant microenvironments.
The sustainable biomodification of the dental tissue will overcome clinical pitfalls associated with failure of
tooth-resin interfaces, particularly dentin breakdown. The ultimate outcome is the development of a PAC-based
intervention approach that can revolutionize dental restoration.

Public health relevance
NARRATIVE Using a bioinspired strategy, this project will use plant-derived oligomeric proanthocyanidins as an intervention material to modify the physicochemical properties of the dentin matrix to enhance the strength and stability of both dentin and the dentin-resin interface. The ultimate goal is to improve oral health by reducing the incidence of secondary caries and failing dental restorations. Minimizing the need to replace dental resin composite restorations will reduce the pain and anxiety associated with dental procedures, improve health, and reduce health care costs.